Fructose Induced Regulation of Profibrogenic Factors in Hepatic Nonparenchymal Cells

PROJECT SUMMARY
NAFLD has become progressively more common in today's society impacting adults and children. High
fructose corn syrup consumption is strongly correlated with diabetes, obesity and nonalcoholic fatty
liver disease (NAFLD). Fructose consumption is two to three times higher in patients with NAFLD
compared to controls and increases the presence of lobular inflammation and fibrosis. The major
contributors of lobular inflammation and fibrosis are activated hepatic nonparenchymal cells (NPCs),
which consist of hepatic stellate cells (HSCs), and Kupffer cells. Fructose metabolism has been
investigated primarily in hepatocytes and is known to induce lipogenesis and oxidative stress. These
events in hepatocytes have been shown to impact Kupffer cell function pushing the cells to an
inflammatory phenotype. However, the distinct role of fructose metabolism on NPCs phenotype and
function in NAFLD is unclear. The broad, long term goals of this project are to identify new mechanism
by which fructose excess leads to the development of NAFLD, by uncovering metabolic pathways
regulated by fructose that impact NPCs function. Preliminary data demonstrate that primary Kupffer
cells and HSCs express KHK and fructose supplementation in vivo, increases tissue inhibitor of
metalloproteinase (TIMP1) expression in Kupffer cells compared to diets supplemented with glucose
or no monosaccharides in drinking water. In vitro, fructose treatment increases intracellular levels of
acetate and formate in macrophages. Based on these observations, the specific aims of this project
are: 1) to determine in vitro the mechanism by which fructose drives a profibrogenic phenotype in
Kupffer cells and 2) characterize the phenotype and fructose metabolism in Kupffer cells under high
fructose consumption during normal and NAFLD liver conditions. Our research design uses both in
vivo and in vitro systems, to investigate the proposed aims. We integrate nuclear magnetic resonance
and liquid chromatography mass spectrometry to trace 13C fructose in vitro (Aim 1) and in vivo (Aim 2)
in Kupffer cells and to identify fructose generated metabolites that regulate fibrogenic gene and protein
expression in NPCs. To investigate the role of TIMP-1 and acetate in Kupffer cells, small interfering
RNA (siRNA) transfections (Aim 1) will be used in vitro. Data obtained from this proposal are expected
to establish a foundation for new mechanisms of carbohydrate metabolism in NPCs and provide critical
insight for the potential development of therapeutic targets for the prevention and treatment of NAFLD.

Public health relevance
PROJECT NARRATIVE Fructose consumption is two to three times higher in patients with nonalcoholic fatty liver disease (NAFLD) compared to controls and increases the presence of lobular inflammation and fibrosis. The major contributors of lobular inflammation and fibrosis are hepatic macrophages and stellate cells. The purpose of this research is to investigate the role of fructose on hepatic nonparenchymal function in order to delineate the consequences of high fructose consumption on the pathogenesis of NAFLD.